Control of Flagellar Filament Length by FlaG in Polarly-Flagellated Bacterial Pathogens

Project Summary
Bacteria produce various macromolecular surface organelles that function in different processes. For many
organelles, it is unclear how bacteria regulate their dimensions or even if a specific mechanism exists to
govern the size or length of the organelle. The flagellum is a surface organelle that facilitates swimming motility
and migration of pathogens to ideal niches in hosts to initiate infection and pathogenesis of disease. Two
specific mechanisms have been discovered in flagellar biogenesis that regulate the length of the periplasmic
rod and surface hook. However, a current hypothesis states that bacteria do not have a specific and active
mechanism to regulate the length of the extracellular flagellar filament, which functions as the propeller of the
flagellar motor and extends ~10 µm on the surface of model peritrichous bacteria such as Salmonella species
and E. coli. Challenging this hypothesis are observations that many polarly-flagellated bacterial pathogens,
such as Campylobacter jejuni, Vibrio cholerae, and Pseudomonas aeruginosa, produce flagellar filaments
~70% shorter than those of peritrichous bacteria. Furthermore, deletion of flaG that is conserved in these
pathogens and many other polar flagellates but absent in peritrichous organisms, caused flagellar filaments to
extend up to twice the length as those of WT cells. In addition, C. jejuni DflaG producing elongated flagellar
filaments displayed a 28-fold defect for cecal colonization of the natural avian host, suggesting that properly
regulating flagellar filament length is necessary for optimal colonization of a host. Together, these findings
indicate that FlaG in polar flagellates is involved in a specific and active mechanism to control the extracellular
length of the flagellar filament and is important for some pathogens to colonize hosts, but a molecular
mechanism for how FlaG controls filament length is unknown. In this proposal, we will use C. jejuni as a model
system for polar flagellates to understand how a bacterium employs FlaG to control the length of the flagellar
filament by halting filament polymerization, an event that occurs at a large distance (~2-3 cell body lengths)
from the bacterial surface. We will test two non-mutually exclusive hypotheses that FlaG controls flagellar
filament length by the following mechanisms: 1) FlaG interfering with interactions between the filament-building
flagellin subunits and the FliS chaperone to reduce flagellin secretion; and/or 2) FlaG functioning as a flagellin
mimic to block flagellins from polymerizing into the filament at the tip of the flagellum. We will also investigate
why production of elongated flagellar filaments by C. jejuni DflaG reduces the ability to colonize a host by
analyzing the effects of elongated filaments on motility efficiency and velocity through different physiologically-
relevant viscosities and secretion of proteins through the flagellum required for host interactions. Outcomes
from this study will provide new knowledge regarding how bacteria control dimensions of macromolecular
surface organelles to maintain proper function for host interactions and steps in pathogenesis of disease.

Public health relevance
Project Narrative Polarly-flagellated bacterial pathogens produce flagellar motors with extracellular filaments significantly shorter than those produced by peritrichous bacteria, which challenges a previous hypothesis that flagellated bacteria do not have an active mechanism to control length of the extracellular filament. We observed that mutation of flaG in the pathogenic polar flagellates, Campylobacter jejuni, Vibrio cholerae, and Pseudomonas aeruginosa, caused elongation of flagellar filaments to up to twice the length of WT strains and a C. jejuni DflaG mutant was impaired for colonization. We will use C. jejuni as a model system to identify a specfic and active molecular mechanism by which FlaG regulates the length of the flagellar filament in polar flagellates and explore why elongated flagellar filaments hinder the ability of C. jejuni to promote optimal colonization of a host.